Molecular Mechanisms Underlying Terminal Nerve Development, GnRH-1 Neuronal Migration, and Olfactory Bulb Formation in Normal and Pathological Conditions

Summary
The GnRH-1 neurons are fundamental for achieving sexual competence and fertility of vertebrates. During
development, the GnRH-1 neurons migrate from the embryonic nasal area into the brain, where they will
eventually take up positions in the hypothalamus to control the release of gonadotropins from the pituitary gland.
Defects in GnRH-1 migration cause various forms of hypogonadotropic hypogonadism (HH) in humans, which
is characterized by delayed pubertal onset, hypogonadism, and infertility. HH in humans manifests clinically as
either Kallmann syndrome (KS) or normosmic idiopathic HH (nIHH). In KS, HH is associated with deficiencies in
the sense of smell and olfactory bulb defects.
Early migration of pioneer/ terminal nerve neurons from the olfactory placode is critical for triggering the formation
of the olfactory bulbs, a necessary step for establishing a functional olfactory system.
Our central hypothesis is that GnRH-1 neurons migrate to the hypothalamus on the Terminal Nerve (TN), and
that the development of the TN is necessary to induce the formation of a functional olfactory system. We propose
that genes that control TN development are distinct from those directly controlling the development of olfactory
and vomeronasal sensory neurons. We further speculate that specific genetic mutations linked to KS and nIHH
can negatively affect the pioneer/TN neurons in a cell-autonomous fashion, causing secondary GnRH-1 neuronal
defective migration or mispositioning.
Our preliminary data suggest that the neurons forming the Terminal Nerve have a distinct genetic from GnRH1,
olfactory, and vomeronasal neurons. Moreover, we identified that several genes linked to KS, nIHH, and infertility
are enriched in the TN neurons.
In this study, we will genetically trace TN development and manipulate the TN to understand the developmental
effects of genes linked to KS and niHH on the development of this nerve. By exploiting mouse genetics, cutting-
edge imaging, single-cell sequencing, and human genomic data, we will discover fundamental cellular and
molecular mechanisms underlying the normal and pathological development of the TN-GnRH-1 system in
mammals. Successful completion of our study will define new transformative parameters for diagnostics and
designing therapeutic approaches for KS and nIHH in humans.

Public health relevance
Narrative The proposed research addresses a relevant public health issue, as defects in GnRH-1 neuronal migration cause various forms of hypogonadotropic hypogonadism (HH), leading to human infertility. This project aims to elucidate the role of specific, mutated genes in humans affected by HH in controlling the development of the pioneer /terminal nerve neurons and, therefore, GnRH-1 neuronal migration and olfactory bulb formation. The proposed research is relevant to the mission of NICDH/NIH and will provide essential information needed for the diagnosis and treatment of hypogonadotropic hypogonadism and reversing infertility in humans.